Deciphering the Molecular Mechanisms Underlying Cholangiocarcinoma Development

Cholangiocarcinoma (CCA) presents a significant clinical challenge with increasing incidence and mortality in the
US. Annually, around 8,000 new CCA cases were diagnosed, with a dismal 5-year survival rate of less than 10%. Extremely
heterogeneous molecular signatures and resistance to immune checkpoint inhibitors (ICIs) and targeted therapies render
surgical resection the most reliable treatment, but early detection is extremely challenging, limiting this option to a small
group of patients. There is an urgent need for biomarkers for early detection and prevention strategies during premalignant
stages. Cholestatic diseases (CD), including primary sclerosing cholangitis (PSC), significantly increase the risk of CCA,
with over 20% of PSC patients developing CCA within one to two decades. While treatments such as UDCA and Farnesoid
X-Activated Receptor (FXR) agonists reduce cholestatic injuries, their long-term effects on CD-to-CCA pathology remain
controversial and underexplored. Additionally, the roles of FXR and Constitutive Androstane Receptor (CAR) in hepatic
tumorigenesis and the regulation of the tumor microenvironment (TME) in CD-CCA contexts are poorly understood.
Our preliminary data indicate that FXR activation promotes the malignant transformation of hepatocytes (HCs) into
CCA in CD settings, an effect diminished by CAR activation. We hypothesize that FXR activation in CD settings promotes
CCA formation by SHP-dependent repression of CAR-mediated transcriptional networks, affecting both tumor-intrinsic
transformation and extrinsic immune clearance.
In aim 1, we will Investigate the intertwined roles of FXR and/or CAR in HC-CCA transformation within a CD
context. We will employ pharmacogenetic tools including innovative inducible gene modulation systems to achieve
conditional and inducible deletion of targets in advanced CCA. In aim 2, we will comprehensively elucidate how FXR/CAR
regulates immune surveillance, reducing CCA in a CD context. We will determine functional contributors in CCA clearance
and assess the ICI combination effect on CD-CCA pathology. In Aim 3, we will delineate molecular mechanisms by which
FXR and/or CAR influence CD-CCA. We will verify FXR-SHP cascade repressing CAR activity regulating CD-CCA and
also explore downstream effectors of FXR and CAR in CD-CCA.
This research aims to elucidate the roles of FXR and CAR in CCA progression and immune regulation, potentially
leading to new biomarkers and therapeutic strategies for early detection and prevention, ultimately improving outcomes for
CD-CCA patients.

Public health relevance
PROJECT NARRATIVE (3 sentences limit) This proposal aims to elucidate the molecular and immunological mechanisms driving cholangiocarcinoma (CCA) development in cholestatic diseases (CD), focusing on the contrasting roles of Farnesoid X-Activated Receptor (FXR) and Constitutive Androstane Receptor (CAR), which are recommended for CD treatment, with CAR inhibitors under trial for hepatocellular carcinoma. We will investigate how FXR activation promotes and CAR activation impedes CCA progression, particularly their effects on immune surveillance, to identify new biomarkers for early detection and develop novel therapeutic strategies, including immune therapy. Thus, this research addresses a critical unmet clinical need and has the potential to significantly improve patient outcomes. 1